Milk Protein-Based Amorphous Solid Dispersion for Delivery of Hydrophobic APIs

PROJECT SUMMARY
We intend to demonstrate that casein proteins from bovine milk can be used to create amorphous solid dispersions (ASD)
of insoluble active pharmaceutical ingredient (API). These casein-based API-ASD can be readily dispersed in water and
used as ethanol-free oral liquid formulations for infants and children. In this proposal, first we will elucidate the key
environmental stimuli conducive to the formation of casein-based ASD with high loading capacity, and excellent instant
properties. The core of the experiments will be conducted using ritonavir, furosemide, and tristearin as hydrophobic
probes. Second, we will determine the stability and release kinetics of ASD in response to pH and to model digestion
systems. We will investigate the environmental stimuli leading to the delivery of the API form the ASD to the aqueous
phase. Third, we will determine the in vivo bioavailability of one casein-based ritonavir ASD and one casein-based
furosemide ASD. We will formulate the two ethanol-free API ASD, disperse in water, and administrate to mice models to
determine bioavailability vs. commercial formulations containing ethanol. The latter experiments will demonstrate that
API-ASDs are dispersible in an aqueous phase and exhibit appropriate absorption through the intestinal lumen.

Public health relevance
PROJECT NARRATIVE In a recent survey, pediatricians identified 35 drugs needing oral liquid formulations tailored to infants and children. We propose to use components in milk (caseins) to deliver low-solubility drugs using formulations that are not different from infant formula. Our proposal aims at creating milk-based instant powders to carry insoluble drugs, in line with stated goals by the Best Pharmaceuticals for Children Act.